Single Cell Transcriptomic and Epigenetic Analysis of CD4 T Cells Harboring Latent HIV during Antiretroviral Therapy

PROJECT SUMMARY
Human Immunodeficiency Virus (HIV) infection remains incurable, despite highly active antiretroviral therapy
(ART) that effectively targets the viral life cycle. A small population of long-lived CD4 T cells harbors replication
competent virus (the latent HIV reservoir) that rebounds when treatment is stopped. The latent reservoir is a
major barrier to curing HIV but is poorly understood due to technical challenges that prevent its characterization.
To address this, I developed an ultra-high throughput droplet microfluidic workflow called PCR activated cell
sorting (PACS) that detects, sorts, and sequences cells containing a single copy of intracellular HIV genomic
DNA. My preliminary work has demonstrated that PACS can 1) process millions of cells, 2) detect HIV DNA in
single cells from ART-suppressed individuals, and 3) sort infected cells and determine their transcriptional
differences by differential expression analysis. Based on these results, PACS provides a unique method to study
HIV infected cells ex vivo.
I hypothesize that there are specific genomic mechanisms in HIV infected cells that allow them to harbor
replication competent provirus and evade the immune system. This proposal couples PACS to single cell
RNA-seq and ATAC-seq in order to define what, if any, are the unique signatures of infected cells in vivo.
Simultaneous sequencing of viral genomes and integration sites (in collaboration with Dr. Kearney) will allow
discrimination of intact from defective virus and provide the unique opportunity to link RNA-seq and ATAC-seq
datasets. This work will use samples from people on ART suppression enrolled in SCOPE, an ongoing
prospective study with carefully curated clinical data, further increasing the translational value of this research.
Understanding the cellular mechanisms that allow HIV to persist in vivo is critical for guiding the selection of
latency reversing agents, and in the development of drugs that specifically target infected cells.

Public health relevance
PROJECT NARRATIVE Infection with Human Immunodeficiency Virus (HIV) is incurable, despite drugs that effectively target the viral life cycle. The reservoir of cells containing replication-competent HIV that persists during drug therapy is poorly understood because these cells cannot be isolated to high purity. This proposal uses a novel microfluidic technology to detect, sort, and study (RNA-seq, ATAC-seq) infected cells from people living with HIV, with the goal of elucidating the molecular basis of HIV latency and informing new eradication strategies.